Biology of Aging and Age Related Diseases Training Grant

Project Summary
Funded by NIA since 1991, this application seeks the 6th competitive renewal for a highly
successful T32 program at the University of Wisconsin-Madison (UW). It requests
continued support for 4 predoctoral and 4 postdoctoral trainees in aging research.
The major mission of this T32 is to provide interdisciplinary, state-of-the-art training to
talented pre- and post-doctoral fellows in both biology and clinical/translational research
in aging and related diseases. Similar to prior trainees, it is projected that the majority of
trainees in the next funding period will pursue successful academic careers, and lead
prominent programs in aging research across the country. This application builds upon
the remarkable resources of UW in gerontology research, and includes 35 (16 women
and 19 men) faculty mentors with acknowledged expertise in aging research. Notably,
the mentors are balanced across the three faculty ranks of professor (18), associate
professor (9) and assistant professor (8), and each mentor has a celebrated history of
conducting cutting edge aging research and training successful scientists in gerontology.
For over 25 years, this T32 has received substantial institutional commitment. The
present application includes significant financial commitments, including support for a
new (i.e., 5th position) predoctoral position each year and funds to cover 5% effort for
both the Program Director and Associate Director annually. Additional strengths of this
application include: 1) inclusion of 16 (46%) new faculty mentors representing emerging
areas in aging research, 2) balanced distribution of mentors between junior, mid-level
and senior faculty ranks, 3) history of over 93% of T32 trainees supported over the past
15 years alone have pursued successful academic careers in aging research, 4)
confirmation that this training program does not overlap with any other T32 at UW, 5)
enhanced efforts to increase recruitment and retention of trainees from
underrepresented groups, and 6) inclusion of an outstanding training curriculum in both
basic biological and clinical research with the addition of several new teaching programs.
Overall, the present T32 will continue to provide outstanding training to talented young
scientists in both laboratory-based and clinical/translational research in aging and
related diseases, and help them launch successful academic careers in gerontology.

Public health relevance
Project Narrative The major mission of this T32 is to train highly talented, well-qualified pre- and post- doctoral fellows in aging research. Given the projected increase in the number of older adults living in the US by 2050, it is critical that significant advances be made toward understanding the biology of aging and related diseases, and to improve management of chronic diseases commonly seen in the elderly. The present T32 Program will provide state-of-the-art training in aging research to young talented scientists, expected to pursue academic careers at institutions throughout the country. These scientists will make novel contributions toward understanding the biology and enhancing management of disabling diseases of aging.